PROJECT 4: Genetic and Structural Basis for Human Antibody Inhibition of Dengue Viruses

One of the primary goals of this P01 program project proposal is to define the functional and antigenic specificity
of the memory humoral response before and after dengue virus (DENV) infection. Here, we will determine the
molecular and structural basis for type-specific and cross-reactive human B cell responses to DENV infection.
Aim 1 of Project 4 will study the epitopes and structures recognized by DENV3 type-specific potently neutralizing
antibodies (Abs). The goal is to define a comprehensive antigenic map of neutralizing determinants on the DENV
E protein, which will inform DENV vaccine design and testing efforts. In past work with investigators in this
consortium, we have mapped many of the major antigenic determinants on DENV1 and DENV2. The protective
determinants on DENV3 are less well studied. Fortunately, in preliminary experiments, in collaboration with
Project 1 and Core C, we have generated a significant panel of potent DENV3-specific neutralizing monoclonal
Abs (mAbs) from the Nicaraguan Pediatric Dengue Cohort Study (PDCS) samples. It is clear that many of these
antibodies recognize novel epitopes that are not previously known. We will use these reagents to identify the
molecular and structural basis for recognition using alanine scanning mutagenesis, hydrogen deuterium
exchange mass spectrometry, cryo-EM and crystallography studies. If the antigenic maps appear incomplete,
as determined by Project 1 in dengue-endemic populations, we will generate additional mAbs from the peripheral
blood mononuclear cells (PBMCs) collected from children with documented repeat DENV3 infections, as well as
DENV1 and DENV2 infections, in the PDCS to define the complete antigenic landscape. We hypothesize that
most DENV3-specific Abs are directed to quaternary epitopes, including those near the DENV envelope domain
I/II (EDI/II) hinge region, but that there is a diversity of binding poses and angles for recognition of this complex
region. In Aim 2, we will define comprehensive antigenic maps for cross-reactive Abs that recognize and
neutralize viruses of all 4 DENV serotypes. In preliminary studies, we have isolated broad and potent mAbs that
have distinct profiles from those of the limited number of E dimer epitope (EDE) mAbs reported to date. The new
mAbs suggest there are additional sites of vulnerability for broad and potent neutralizing responses that are not
yet understood. Studies in this aim will define with biochemical, genetic and structural approaches the novel
epitopes associated with highly neutralizing cross-reactive mAbs that differ from EDE epitopes after 2° DENV
infection. Finally, in Aim 3, we will use emerging techniques in adaptive immune receptor next generation
sequencing to interrogate the Ab variable gene repertoires in PDCS subjects. We will use deep sequencing of
peripheral blood Ab gene repertoires in prior (pre-2° infection, pre-vaccination) PBMC samples from the same
individuals. These studies will provide a global view of repertoire responses that will complement the molecular
‘snapshots” afforded by mAb studies in Aims 1 and 2. The repertoire studies will elucidate the complexity and
specificity of the human B cell response to DENV infection on a more systematic level. The P01 integrates the
work of several laboratories with expertise in different aspects of DENV biology and adaptive immunity. The
human mAbs isolated in Project 4 will be used to study the molecular, structural and genetic basis for neutralizing
responses but also will generate and distribute key mAb reagents that facilitate the studies in Projects 1 and 2
in this P01. Chimeric antigens produced on Project 2 will be used to identify subjects with novel B cell responses,
and also to map new mAb specificities. The tasks proposed here could not be performed by any single laboratory
in the P01 because of the expertise needed in Ab engineering and deep sequence analysis, the scale of
production required, and the need for unique dengue reagents, cohort participants, and molecular biology
approaches. Understanding human B cell responses to DENV at both the clonal and overall genetic repertoire
level promises to give significant new insights into the molecular and genetic basis for type-specific and crossreactive
human B cell responses.

Public health relevance
The human B cell and antibody response to dengue virus infection is correlated with protection against disease, but the molecular features of this response are incompletely understood. In this project, we will follow up results from the initial Program Project and isolate and characterize in depth human monoclonal antibodies to dengue virus from subjects in the Nicaraguan Pediatric Dengue Cohort study, working in close collaboration with other Projects and Cores. The studies will use serotype-specific and cross-reactive antibody clones and advanced next generation deep sequencing immune repertoire techniques to determine the molecular, structural and genetic basis for the human antibody response to dengue.